HSR&D Senior Research Career Scientist Award

The Senior Research Career Scientist (SRCS) award will support Dr. Corrine Voils to further contribute
her scientific, mentoring, and service capabilities to the VA. Her research focuses on identifying effective
behavioral strategies to promote maintenance of health behaviors to improve health outcomes. She conducts
rigorous randomized trials to evaluate theoretically based interventions for weight loss maintenance. She is
also leading development, validation, and dissemination of a self-report measure of medication nonadherence.
Since 2005, Dr. Voils has maintained a diverse portfolio of VA and National Institutes of Health (NIH)
funding. She has been awarded over $13 million dollars as a Principal Investigator (PI) and another $32 million
as Co-Investigator. She is currently PI of 1) a single-site randomized trial to evaluate the comparative
effectiveness of a participant-only to partner-assisted intervention for long-term weight loss and 2) a multi-site
trial to evaluate the effectiveness of providing variable financial incentives for dietary self-monitoring, weight
loss, or both compared with no incentives for weight loss initiation and maintenance. She is also Multiple PI of
the KL2 career development program at the University of Wisconsin’s (UW) Institute for Clinical and
Translational Research, which provides a series of professional development seminars and workshops to VA
and non-VA career development awardees. In the past three years, Dr. Voils has been first or senior author on
30 manuscripts and coauthor on another 28; more than half of these have been with mentees. In recognition of
her scientific contributions, Dr. Voils was elected in 2014 as a Fellow of the Society of Behavioral Medicine.
In addition to leading an innovative research program, Dr. Voils has a unique skillset that makes her a
highly pursued collaborator and mentor in behavioral theory, intervention development, measurement and
survey design, randomized trials, and qualitative methodology. She have been a Co-Investigator or mentor on
more than 35 projects funded by VA, NIH, AHRQ, and non-federal sources. These studies have spanned the
areas of medication management, hypertension and diabetes self-management, colorectal cancer screening,
palliative care, smoking cessation, surgery, caregiving, and infection control.
Dr. Voils is building capacity for health services research at her institution and beyond through
individual mentoring and leadership. She has been primary mentor for four career development awardees and
a mentoring team member for several others. Several mentees have transitioned to independence.
Dr. Voils provides service to benefit the VA through committee membership, peer-review, and
leadership. Since 2011 she has served as the only VA faculty member at the NIH Summer Institute on Design
and Conduct of Randomized Clinical Trials Involving Behavioral Interventions. This Institute provides early-
career faculty with didactic training and consultation regarding design and implementation of trials of behavioral
interventions. A VA perspective is critical for VA attendees. As a KL2 Director, Dr. Voils provides the VA
perspective to the program, which directly supports VA career development awardees through its
programming. As Director of the Wisconsin Surgical Outcomes Research program, Dr. Voils is responsible for
building capacity for conducting surgical health services research inside and outside the VA.
Dr. Voils’ specific aims for the SRCS award period include: 1) conduct innovative, high-impact studies
that inform VA clinical practice regarding effective interventions for weight loss maintenance, 2) disseminate
and apply mentoring best practices by offering mentor and mentee training workshops, publishing papers on
application of these principles in career development award communities, and increasing the number of career
development awardees at her site and nationally, and 3) continue and expand service to VA through
committee service, peer review, and facilitation of cross-site collaborations for health services researchers in
the Midwest and beyond.

Public health relevance
I dedicate my career to identifying effective behavioral interventions to promote behavior maintenance and improve Veteran health outcomes. I have contributed to over 45 million dollars in research funding, including as current Principal Investigator of two randomized trials. I have been the primary mentor for four career development awards and a key part of the mentorship team for others. In the past three years, I have published 58 manuscripts, with more than half as first or senior author and coauthored with mentees. I serve the VA through committee participation, peer review, and leadership. My research addresses Health Services Research & Development priorities of primary care practice and whole health. It also addresses the Office of Research & Development strategic priority of increasing Veterans’ access to high-quality clinical trials.